SC1:Functional Investigation of Neural Elements Located in a Key Brainstem Circuit that Controls Attention

? DESCRIPTION (provided by applicant): The goal of this project is to identify the function of previously uninvestigated neuronal elements and circuits located in key brain stem regions that control and regulate pre-attentive processes. Pre-attentive processes are impaired in many neurological disorders including schizophrenia and obsessive compulsive disorder which affect 1-3% of the worldwide population and about 4 million people in the United States. Therefore, better understanding the neuronal basis of pre-attentive processes will have a powerful impact on health concerns both nationally and internationally. At the present time, there is no treatment for dysfunction in attention processing, a cognitive task that governs a variety of behavioral outcomes. In fact, individuals unable to focus attention for prolonged periods of time will struggl to learn in school, to maintain a job and to participate in social activities. Despite much scientiic efforts, the neural circuits and mechanisms underlying pre-attentive processes are still ill defined, even in healthy subjects. We will use an animal model and state-of-the-art neuronal recording techniques to better understand brain stem circuits and mechanisms controlling pre-attentive processing. Such neuronal pathways and mechanisms could be targeted for drug development and therapeutic strategies for disorders accompanied with pre-attentive deficits.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims at better understanding previously unknown and unidentified brain circuits that help us focus attention by blocking irrelevant sensory information reaching the brain. Such irrelevant information impairs the brain activity of individuals suffering from psychiatric or neurological disorders such as schizophrenia and obsessive-compulsive disorder. This is because brain information overload is associated with symptoms such as hallucinations and obsessions that greatly impair the life of about 3% of the worldwide population. Here, we will use an animal preparation and state-of-the-art neuronal labelling and recording techniques to identify key neuronal circuits controlling how the brain focuses attention. Such circuits represent promising targets for drug development that will help patients suffering from attention deficits.